Cell type signaling specificity of the neurodevelopmental disease-associated DYRK1A kinase

PROJECT SUMMARY/ABSTRACT
Mutations in DYRK1A, which encodes a ubiquitously expressed kinase that antagonizes the calcium-
dependent calcineurin (CaN)/NFAT signaling pathway, have been reproducibly linked to neurodevelopmental
disease. DYRK1A loss of function has been associated with syndromic intellectual disability and autism
spectrum disorders (ASD), and increased DYRK1A activity is thought to underlie aspects of Down Syndrome
pathophysiology. These genetic clues underscore DYRK1A dosage-dependent regulation of nervous system
development; however, the precise mechanisms by which DYRK1A executes its roles in the developing brain
remain poorly understood. Our long-term goal is to understand how DYRK1A acts in specific cell types of the
embryonic cerebral cortex to influence the commitment of neural stem and progenitor cells to specific neural
fates. In the proposed studies, we focus on NFAT-dependent transcriptional mechanisms as primary effectors
of DYRK1A activity in neural stem cells and their progeny.
We have found that deleting Dyrk1a specifically in the developing cortex differentially impacts calcium
signaling in neural stem/progenitor cells and neurons of both the mouse and human. Loss of one or both
copies of Dyrk1a results in dose-dependent cortical thinning, depletion of radial glia stem cells, reduced
astrocyte abundance, neuronal cell death, and shifts in excitatory neuron differentiation. Our previous studies
uncovered similar changes in the generation of excitatory neuron subtypes resulting from the mutation in the
Cav1.2 calcium channel that gives rise to the syndromic ASD Timothy Syndrome. Imbalances in these same
excitatory neuron types have also been linked to neuropsychiatric syndromes and channelopathies, hinting that
calcium-regulated molecular mechanisms may represent a core substrate underlying cellular phenotypes in
ASD and other neurodevelopmental disorders. In line with this idea, we have found that the effects of Dyrk1a
deletion during cortical development are phenocopied by in vivo modulation of CaN/NFAT signaling, and we
have used CUT&RUN sequencing to begin to identify NFAT transcriptional targets in the developing brain.
Building on these strong published and preliminary findings, the central objective of this proposal is to define
cell type-specific mechanisms by which DYRK1A regulates the development of the cortex. The proposed
research tests the ideas that NFAT transcriptional targets underlie deficits in stem cell maintenance and
differentiation resulting from cortex-specific Dyrk1a inactivation (AIM 1), that DYRK1A and calcium signaling
through CaN/NFAT play key roles in cortical astrogliogenesis (AIM 2), and that cell type-specific NFAT targets
contribute to DYRK1A signaling specificity (AIM 3). These studies will build a foundation for future research
expanding our knowledge of how calcium signaling regulates brain development and how ubiquitously
expressed disease-relevant genes exert specific functions in different cell types. Our results will also provide
therapeutic entry points for convergent intracellular mechanisms driving neurodevelopmental disorders.

Public health relevance
PROJECT NARRATIVE Loss-of-function mutations in the DYRK1A gene have been tightly linked to neurodevelopmental disorders like autism spectrum disorders and intellectual disability. The research described in this proposal aims to uncover specific mechanisms by which DYRK1A influences the function of immature neural stem and progenitor cells in the developing brain and their commitment to specific neural identities. The results of our studies will identify potential therapeutic entry points for neurodevelopmental disorders by defining intracellular signaling pathways regulated by DYRK1A that can be modulated to restore normal brain function.